2022 Musculoskeletal Biology & Bioengineering Gordon Research Conference & Gordon Research Seminar

ABSTRACT
Since 1980, the biennial Gordon Research Conference (GRC) on Musculoskeletal Biology and
Bioengineering has been the leading forum for the presentation and discussion of new and unpublished
information in the field. Because of the ample opportunity for discussion and interaction, this meeting has
invariably led to new collaborations, initiatives and research directions. An important career development event,
programming at this GRC is designed to recruit and support the success of diverse new investigators in the
musculoskeletal field. Post-conference evaluations consistently rate the conference as “outstanding”. Funds are
requested for partial support of the 2022 Musculoskeletal Biology and Bioengineering GRC, which is to be held
again at Proctor Academy in Andover, NH, a calm, scenic, and isolated site that fosters maximum interactions
among the participants. The theme for the 2022 GRC is “Accelerating Discovery in the Musculoskeletal
System.” This theme was chosen to feature ideas and emerging technologies that will speed our progress in
understanding the integrated function of the musculoskeletal system in development, at homeostasis, and across
the wide range of human aging and disease. Our goal is to not only to highlight the very best and most exciting
work in our field, but also to incorporate the best ideas from beyond our field, to spur new ideas and collaborations
for all attendees. To this end, we will engage new and diverse talent in musculoskeletal research by providing
an inclusive and equitable environment for all investigators.
The meeting will consist of 9 sessions (all plenary and involving invited speakers) and two 2-day poster
sessions. Afternoons will be free for interactive recreation and discussion and the total number of attendees is
capped at 180 to encourage interaction. The GRC will be preceded by a two-day Gordon Research Seminar
(GRS) at the same location, whose theme “Emerging Technologies Shaping Musculoskeletal Research”
complements the GRC program. GRS attendance is expected to be 50 individuals, most of whom will also attend
the GRC. The GRS co-Chairs have worked closely with the Chair and Vice-Chair of the GRC to develop the
scientific program, which includes a mentoring component focused on effective career transitions for new
investigators. Other than a keynote session and a career panel of established investigators, the GRS features
research of new investigator attendees in 2 oral sessions and 2 poster sessions. Along with the larger GRC
organization, the leaders of this meeting have designed both the GRC and GRS to improve diversity, equity, and
inclusion of our field. Both meetings feature outstanding scientists, including many from underrepresented
groups. The GRC Power Hour will address challenges women face in science, as well as intersectionality with
race, sexual orientation, gender identity, and disability. Thus, the scientific and professional activities of this
meeting prepare this community to address the large unmet burden of musculoskeletal disease, especially in
aging, and its disproportionate impacts on women and minoritized groups.

Public health relevance
PROJECT NARRATIVE The 2022 Gordon Conference on Musculoskeletal (MSK) Biology and Bioengineering, themed “Accelerating Discovery in the Musculoskeletal System”, will feature ideas and emerging technologies that will expedite our progress in understanding the integrated function of the musculoskeletal system in development, at homeostasis, and in aging and disease. We have specifically designed the program to be `agnostic' of tissue type, and instead are promoting the idea that the best work happens when researchers cross disciplines, technologies, and tissue types. By bringing together established and new investigators in a secluded location, engaging them in unique sessions designed to highlight multi-disciplinary research, and providing ample time for discussion, mentorship, and interaction, this meeting promises to increase the diversity of our field and to drive the exchange of innovative ideas to advance the pace of discovery and develop novel treatments for MSK disease.